IMMUNE RESPONSE GENE REGULATION OF IMMUNE RESPONSE IN VITRO

The cellular expression of immune response (Ir) gene function was studied in both primary and secondary in vitro antibody responses to the TNP conjugates of (T,G)-A--L and (H,G)-A--L. The function of accessory cells in responses to TNP-(T,G)-A--L and TNP-(H,G)-A--L is under the control of genes which also map to I-A. In contrast, the expression of Ir gene function by B cells is related to the B cell activation pathway; Ir gene function is expressed by B cells activated under conditions involving MHC-restricted T-B interaction. In vitro augmented primary and secondary responses to TNP-nuclease (TNP-NASE) have also been established and documented to be under the control of H-2 linked Ir gene(s) mapping to the I-B subregion. For these responses, accessory cell function was shown to be under Ir gene control. Recent data employing monoclonal anti-Ia reagents have suggested that genes in the I-A subregion may also be involved in regulating responses to TNP-NASE. In order to further analyze the genetic regulation of T cell responses to NASE, a series of cloned lines were generated in BALB/c (H-2d) as well as (H-2b x H-2a)F1 T cells. Individual BALB/c clones were restricted to recognizing NASE in the context of either I-Ad or I-E products. Individual F1 clones were specific for NASE in association with either H-2a or H-2b antigen-presenting cells and subregion mapping studies are currently in progress. The antigen fine specificity of cloned NASE-specific T cells is also being probed through the use of mutant NASE molecules, synthetic peptides corresponding to segments of NASE, and monoclonal antibodies specific for different determinants on the NASE molecule.